Advanced Lab Technologies Core

PROJECT SUMMARY/ABSTRACT: Advanced Lab Technologies Core
One of the greatest added values of the HU CFAR has been facilitated member access to new and emerging
technologies. Science is accelerated by changes in technology, and the evolution of flow cytometric, imaging
and genomic techniques continues at a rapid pace. However, access to such technologies and associated
computational methodologies is an ever increasing and challenging barrier to individual investigators.
Acquisition and optimization of instrumentation and softwares and making them accessible remains the
primary focus of the HU CFAR Advanced Lab Technologies Core (ALTC). Making these cutting-edge
technologies available to HU CFAR users adds critically needed value to their studies of HIV reservoir and
cure, virus-host interactions, therapeutic interventions, and vaccine development. The consolidated ALTC
offers a unified pipeline of immunology services, molecular biology services, and training opportunities
strategically placed to serve the greater Harvard community at the most effective fiscal value. Indeed, the
ALTC serves hundreds of HU CFAR users and their global collaborators supported by more than 100 NIH-
funded grants/contracts across ten different NIH Institutes and Centers.
The ALTC also continues to focus on providing critical individualized technical support to Early Career
Investigators (ECIs), including 20 Developmental and Mentoring Core awardees. At the current time, much of
the identified need for members is in the capture of information regarding the phenotypic and functional state of
individual cells, indexing these samples, and then capitalizing on this precious biomaterial to develop a
comprehensive picture of the genomic landscape that exists in particular disease states. To ensure that all
Harvard CFAR laboratories have access to this remarkable analytical power, this core will facilitate access to
such technologies through the following aims: 1) Provide HU CFAR member access to state-of-the art
instrumentation and techniques.2) Provide user training in all ALTC technologies, as well as computational
assistance. 3) Build a virtual community using state of the art sharing and distribution tools. 4) Expand
essential infrastructure support for HU CFAR investigators conducting clinical and basic science research
related to HIV infection, HIV-associated comorbidities and coinfections, HIV prevention, and Ending the HIV
Epidemic efforts.